Sex differences in a cytokine controlling antibody class switch recombination

Project Summary
This is an R21 application from Dr. Daniel Lingwood (PI), an Associate Professor of Medicine at the Ragon
Institute of Mass General, MIT and Harvard, whose research program defines fundamental rules of B cell
‘decision making’ to inform antibody vaccine design. His laboratory has developed and tested leading structure-
based candidate universal influenza vaccine immunogens within purpose-built transgenic mouse vaccine models
that recapitulate human antibody diversity and development. This has culminated in Dr. Lingwood’s principle of
‘pathway-amplification’, wherein natural antibody gene-hardwired antigen-target solutions can be accessed and
expanded by rationally designed vaccines. In this application, Dr. Lingwood proposes to mechanistically define
how B cell class switch recombination (CSR), a core immune reaction underscoring all humoral immunity (e.g.
IgM -> IgG), is modulated by sex differences in hormones and circulating cytokines. Adaptive immunity, including
the generation of IgG, is often elevated in females, however mechanistic reasons are lacking. In preliminary data,
Dr. Lingwood finds that the circulating levels of APRIL, a cytokine that stimulates CSR independently of
conventional T cell help, is lower in male compared female mice. Antibody responses to T cell/thymus-
independent (TI) antigens (non-protein pathogen features such as bacterial glycan polymers and lipids) are
dependent on ligation of the APRIL receptor TACI and Dr. Lingwood shows that IgG switching within this pathway
is correspondingly higher in females. The sex differences in both APRIL and IgG switching can be reversed by
male gonadectomy (GDX) to remove circulating testosterone. Dr. Lingwood will now test the central hypothesis
that testosterone suppresses APRIL, lowering the class switched IgG in response. In Aim 1, Dr. Lingwood will
apply molecular tools to modulate the circulating concentration of APRIL and testosterone in mice to assess
hormone feedback on APRIL and ultimate control over IgG switching within the TACI-dependent TI-response
pathway. In Aim 2, Dr. Lingwood will deploy a model of bone marrow chimerism his laboratory has developed to
stably engraft the host lymphoid organs with sex-mismatched CD45+ leukocytes (macrophages, granulocytes,
monocytes and T and B lymphocytes). This system will experimentally distinguish cell intrinsic (e.g. XX vs XY)
from environmental (testis vs ovary vs APRIL) contributions to sex differences in antibody CSR in vivo.
Collectively this proposal aims to rigorously define a new mechanism for sex-based control over a core immune
reaction that is at the foundation of humoral immunity.

Public health relevance
Project Narrative B cell class switch recombination (CSR) is a core immune reaction that forms the basis for antibody-based protection against diverse pathogens including bacteria, viruses and fungi. Our proposal aims to define the mechanism by which CSR is regulated by sex hormones and associated sex differences in circulating cytokines within mice. Our goal is to elucidate how this governs antibody output, a control axis that is also present in humans, but is not explained mechanistically.